High-throughput screening of arrayed single cells for automated analysis of phenotypic heterogeneity

ABSTRACT Celldom is developing a high-throughput single cell analysis platform that can screen tens of thousands of single cells per experiment, and use high-resolution genomic analysis to explore the mechanisms driving heterogeneous responses within a cell population, such as resistance to a drug. The company received a Phase I grant and successfully demonstrated a platform that can organize up to 100,000 single cells on a standard cell culture plate sized device, and then track the growth rates of single cell clones over multiple days. This Phase II proposal aims to advance a functional platform for phenotyping and genotyping each cell clone in massively parallel format to realize a comprehensive `multi-omics' single cell analysis platform. We hypothesize that Celldom products can seamlessly integrate the isolation, stimulation, phenotyping, and genomic analysis of clonal populations in a combined workflow. Once this is demonstrated, Celldom's future products will be positioned as the only platform on the market capable of connecting complex phenotypes (i.e., growth rate and cell cycle staging) to expression profiles of single cell clones in massively parallel format. The work plan to achieve this goal is described in three specific aims. In the first aim, we will quantify heterogeneity of single cell growth rates in drug sensitive and resistant cell lines. This aim will demonstrate a high-throughput single cell based drug-screening platform validated with an acute myeloid leukemia (AML) cell line. We will show that the fraction of FLT3+ drug-resistant cells spiked into the parental drug-sensitive cell line can be accurately identified in the Celldom platform. In the second aim, we will demonstrate the ability to conduct high-throughput mRNA expression analysis using mixtures of each cell clone. This aim will demonstrate a genomic workflow for transcriptional profiling of each surviving clonal population. We will print DNA barcodes in each trap site and show that the hydrogels can efficiently entrap cell lysates and limit cross-contamination, as demonstrated with a mixture of human and mouse cell populations. In the third aim, we will demonstrate the ability to combine phenotyping and genotyping in cell lines and primary patient samples. This aim will demonstrate the ability to quantify heterogeneous proliferation rates in patient-derived AML samples exposed to a second generation FLT3-inhibitor continuously over several days, and then couple the phenotypic data to the transcriptional profiles of the surviving clonal populations. Once these aims are demonstrated, we will scale our launch in bottom up fashion, starting with academic core labs and key opinion leaders, expanding to biopharma industry as the Celldom system gains acceptance.

Public health relevance
NARRATIVE Cancer patients often relapse because their tumors contain drug-resistant cells, which though initially present at small fractions, become enriched during treatment to yield incurable tumors. Traditional approaches to identify, isolate, and then examine drug-resistant cells can require months of labor- intensive work, which is prohibitive for the early stages of candidate identification. Single cell assays hold great potential for probing rare cellular events; however, competitor offerings are unable to comprehensively analyze both the phenotype and genotype of each cell. In this Phase II proposal, Celldom will solve this problem by developing a validated workflow that can be first translated into the drug development, and later, clinical marketplaces.